Biomedical Engineering Core

ABSTRACT
Precision Medicine (PM) is revolutionizing the care of patients by tailoring treatment options based on the
molecular composition of their disease. To secure the necessary molecular information, liquid biopsies represent
an exciting source of molecular markers because of the minimally invasive nature of securing them, the plethora
of marker types (circulating biological cells, cell-free molecules [proteins, micro-RNA, cell-free DNA] and
extracellular vesicles [exosomes]), and the diverse molecular information they carry. The challenge with the use
of these exciting markers is that the disease-associated liquid biopsy markers can be a vast minority in a mixed
population making it difficult to secure high-quality results. This is partly due to a lack of platforms for their efficient
isolation and tools to analyze the limited numbers of diseased molecules contained in a liquid biopsy isolate. The
use of microfluidics has become a valuable platform technology to generate high quality isolates that can be fed
into molecular analysis technologies such as NGS to secure results to guide treatment decisions in the clinic
(i.e., translational research) as well as driving basic discoveries. The KIPM COBRE’s Biomedical Engineering
Core (BME Core) is a unique Core within the medical enterprise and consists of two units: (i) Plastics Engineering
Unit (PEU); and (ii) Liquid Biopsy Unit (LBU). The PEU has enabling infrastructure built during the Phase 1
funding of KIPM including a state-of-the-art cleanroom with patterning equipment possessing the ability to
generate both microstructures and nanostructures and production equipment to support large-scale clinical
studies associated with KIPM’s RPLs and outside users. The LBU uses microfluidic devices emanating from the
PEU that possess unprecedented figures-of-merit to analyze liquid biopsy markers. The LBU also has liquid
handling robots to automate the microfluidic workflow. Both units operated collaboratively to support the Phase
1 junior faculty projects as well as many external projects from the KU community and nationally. The activities
of the BME Core and their unique hardware and molecular assays are enabled by collaborations with a P41 NIH
National Biotechnology Resource Center, directed by the mPI of KIPM (Soper), and whose mission is to deliver
innovative technologies into the biomedical community. In the KIPM Phase 2, the BME Core will seek to add
new resource capabilities to both units support the RPLs to facilitate their securing funding from different federal
agencies. These capabilities include nanopatterning to generate new innovative tools and assays for the analysis
of a variety of molecular types, the efficient isolation of cell free DNA to support NGS studies by the RPLs using
a unique microfluidic device, and a highly innovative single-molecule sequencing strategy. The BME Core will
strive to develop business models to sustain long-term operation, increase visibility to recruit external users, and
maintain a seasoned staff. Long term operation of the LBU will be facilitated by partnerships with the private
sector to supply tools to the unit. Dissemination of new discoveries will be facilitated through a robust website,
meeting participation, and timely publications.